Novel Therapeutics for Long QT Syndrome

Project Summary:
Abnormal ion channel function in heart muscle cells induces cardiac arrhythmias such as long QT syndrome.
In preliminary experiments using pharmaceutical approach, we found that activation of Sigma 1 receptor could
alleviate the cellular phenotypes in human induced pluripotent stem cell (iPSC) and mouse models of the
genetic cardiac arrhythmias. The goal of this study is to examine the molecular mechanism underlying the
beneficial effect of Sigma receptor 1 activation on the phenotypes in cardiac ion channel regulation, action
potentials, contraction, mitochondrial function and gene expression in the genetic arrhythmia models. We will
use human iPSC and rodent models to accomplish our goal. In addition, we will design and develop new
Sigma 1 receptor agonists that are more suitable for cardiac arrhythmias, taking advantage of our expertise in
medicinal chemistry. Therefore, our translational study will provide new opportunity of drug development for the
genetic syndromic disorders.

Public health relevance
Project Narrative: This project will investigate the molecular mechanisms of genetic cardiac arrhythmias, taking advantage of new technology to test drug candidates in cardiac muscle cells derived from human patients. This translational approach will open new avenue to identify novel therapeutics for cardiac arrhythmias.